The Impact of Sex and Hippocampal Angiotensin II on Alzheimer's Disease

Abstract
Alzheimer’s disease (AD) is the most common form of dementia in the aged population. An ongoing
conundrum within the AD field is that despite women with dementia outnumbering men two to one, the efficacy
of hormone replacement therapy appears to be limited. This suggests that the mechanism responsible for the
increased risk of AD in women extends beyond direct hormone activity, wherein the neurobiological effects of
sex hormones are dependent on other variables (e.g., angiotensin II). We and others have demonstrated that
angiotensin II, a critical mediator of vasoconstriction, can amplify AD hallmarks in the brain, such as oxidative
stress, amyloid plaques, and neurofibrillary tau tangles. We also discovered that the female sex chromosome
XX is associated with increased angiotensin II activation compared to XY. Further, previous work has shown
that androgens can upregulate angiotensin II signaling, whereas estrogens can downregulate angiotensin II
signaling, alluding to a link between the sex hormones and angiotensin II activation. Notably, post-menopausal
women have higher levels of androgens than estrogens and exhibit increased angiotensin II activity compared
to aged men, which may explain their increased risk for developing AD. We hypothesize that cognitive
impairment and increased AD risk in post-menopausal women is related to upregulated angiotensin II
activation from XX sex chromosome and higher androgens levels due to loss of ovarian estradiol. We will test
this hypothesis directly in aged male and female TgF344-AD rats and four core genotype (FCG) rats. We
propose three specific aims 1) To determine the role of circulating hormones on modulating brain angiotensin
II-associated oxidative stress and cognitive impairment, 2) To examine the role of brain-derived hormones on
modulation of angiotensin II-associated oxidative stress and cognitive impairment, 3) To determine the
independent effects of sex hormones and sex chromosomes on angiotensin II-associated oxidative stress and
cognitive impairment. Our integrative approach will allow us to elucidate mechanisms involved in the observed
sex differences in AD, in which post-menopausal women are at the highest risk for AD and cognitive decline.
These proposed studies will be the first to examine the interaction between sex chromosomes, sex hormones,
brain-derived hormones, and brain angiotensin II activation on accelerated brain aging and cognitive decline.

Public health relevance
Public Health Narrative Women have a two-fold increased lifetime risk for Alzheimer’s disease (AD) compared to men, an effect that cannot be fully remediated by estrogen supplementation, suggesting that the underlying mechanism is complex. Recent reports have suggested that angiotensin II (ANG II) is involved in AD pathogenesis and that post-menopausal women have higher ANG II activation than aged men. The goal of these studies is to elucidate sex differences in AD pathogenesis by examining the interplay between sex hormones, sex chromosome complement, and ANG II signaling, which may explain the increased incidence of AD in women.